3D Bioprinting of Strong Living Scaffolds

Project Summary
The regeneration of damaged or diseased tissues that serve biomechanical functions, such as musculoskeletal
tissues, has been a long-standing challenge in clinical practice and research. Regenerative engineering offers
a promising alternative to auto- or allografts for tissue regeneration by combining biomaterial scaffolds, viable
cells, and bioactive factors. Engineering scaffolds that provide both mechanical support and biological activities
is critical for regenerating such tissues with biomechanical functions. However, currently existing scaffolds,
which include either tough polymers with limited bioactivities or soft hydrogels with poor mechanical properties,
fall short of meeting both mechanical and biological needs. To address this issue, we propose the development
of a novel family of emulsion bioinks to enable the 3D bioprinting of strong living scaffolds with built-in
mechanical robustness and desirable biological functions for tissue regeneration. The encapsulation of
biologics (cells and bioactive factors) within scaffolds presents an attractive strategy to equip the scaffolds with
desired biological functions. The major roadblocks to encapsulate biologics within tough polymers include their
lack of bioactivity and the frequent usage of harmful chemicals, such as organic solvents and/or toxic reactants.
In this study, a water-in-oil emulsion bioink is designed by dispersing an aqueous internal phase of hydrogel
droplets (microgels) with encapsulated biologics in an external phase of tough polymer solution. It is
hypothesized that microgels will protect the functions of encapsulated biologics from harmful chemicals by
limiting their diffusion from the external to internal phases. The solidification of tough polymer around each
dispersed microgel during 3D-bioprinting will mainly contribute to mechanical robustness of the final scaffold.
The preliminary data demonstrates that: 1) >95% viability of fibroblast cells is achieved in an emulsion bioink;
and 2) the resulting emulsion scaffolds afford both the mechanical robustness (elastic moduli 5-40 MPa)
and >90% cell viability. This project will initiate with the development of cytocompatible and bioprintable cell-
laden emulsion bioinks, followed by characterization of 3D-bioprinted emulsion scaffolds, and conclude with
validating the functions of encapsulated bioactive factors and cells within scaffolds for meniscus regeneration
as a test model. This model will include assessments of proliferation, fibrochondrogenic differentiation in vitro,
and neo-menisci formation in vivo. Overall, our approach presents a new method to produce mechanically
strong and biologically functional living scaffolds by integrating emulsion chemistry and 3D bioprinting
technology. We anticipate that this work will have a broad and significant impact on regenerative engineering
by benefiting repair or regeneration of broad-spectrum tissues with biomechanical functions.

Public health relevance
Project Narrative Regenerative engineering approaches represent a promising treatment modality to repair or regenerate damaged/diseased tissues. Engineering a mechanically strong and biologically active scaffold is highly desirable for the regeneration of broad-spectrum tissues with biomechanical functions, such as bone, tendon, ligament and cartilage; however, it remains challenging. We will develop an emulsion bioink and utilize 3D printing technology to generate mechanically strong `living' scaffolds for tissue regeneration.